Developmental Research Program

PROJECT SUMMARY
The DF/HCC Lung SPORE Developmental Research Program (DRP) is essential to the growth and future
success of our SPORE program because it is a mechanism to advance high quality, innovative lung cancer
research proposals from the pilot stage to full-fledged expanded projects, including future SPORE projects. We
will leverage the DRP to create opportunities for research development of a diverse range of both junior faculty
and senior investigators with an interest in lung cancer and to stimulate new research ideas and new
collaborations. Both basic science and translational projects will be considered, and we have a robust plan to
encourage and promote proposal submission by researchers from underrepresented minority groups, diverse
specialties and from women.
The DRP will initiate a broad call for proposals that will be circulated widely through the help of our faculty, our
Governance Committee, and our Diversity and Inclusion Advisory Committee to ensure the most promising early-
phase research projects receive meritorious funding. Investigators at all DF/HCC member institutions will be
eligible to submit applications, in addition to some partner institutions throughout Boston. Applications will
undergo a formal standardized review process, with a large scientifically-diverse committee of reviewers, to
assess scientific merit, potential impact, the applicant’s credentials, and likelihood of success and progression
to independent funding. Awards are intended to be two years in duration, but each project will be reviewed at
the one-year mark to ensure that reasonable progress is being made prior to the second year of funding.
Recipients of DRP funding will participate consistently in the SPORE program with posters and/or presentations
at the Annual Lung Cancer Retreat, and regular mentoring by the DRP leadership. We have secured significant
institutional funding to supplement Federal funds, allowing multiple DRP awardees per year and allowing each
awardee to be supported for up to two years. The DF/HCC has a large and talented investigator group to provide
a wealth of applications from which to choose, and we anticipate a robust response to each request for
applications that is announced.